Administrative Core

PROJECT SUMMARY - Administrative Core
This University of Vermont COBRE will be focused on Translational Research to Prevent and Control Global
Infectious Diseases. Abbreviated as “The TGIR Center” (Translational Global Infectious Diseases Research),
the Center's mission will be to integrate a novel multi-disciplinary research team of biomedical and
mathematical/computational scientists, including four talented junior faculty. This team will work toward novel
and impactful research to diminish the burden of globally-important infectious diseases and to bridge the
culture gaps between the biologic and mathematical/computational fields of biomedical research. The
Administrative Core (AC) of the TGIR COBRE will be its administrative and intellectual hub. The processes of
the AC will include organization and scheduling, strategic planning, tracking milestones and metrics, and
financial management and reporting. The core will manage and assess all TGIR center features, including
educational components, the two research cores (Human and Population Research; Mathematical and
Computational Predictive Modeling), the mentoring and career development program, assessment of junior
faculty progress and hiring/replacement of faculty. Innovative features include a 2:1 (mentor: junior faculty)
mentoring plan, a predictive modeling “Brains Trust,” a visiting scholar seminar series, and “Research
Navigator” consultations. The administrative team of the AC is an experienced and knowledgeable team with
an established history of careful management, leadership and collaboration.